Community Liaison and Recruitment Core

ABSTRACT
The Community Liaison and Recruitment Core (CLRC) will work together with the other cores of the San Diego
Alzheimer’s Disease Resource Center for Minority Aging Research (SD AD-RCMAR) to train Scientists to
understand and employ a community-engaged approach to research targeting multilevel factors to inform
interventions addressing inequities in ADRD among Hispanics/Latinos, limited English proficient (LEP), and
refugee communities (our priority populations). These priority populations are the focus of the SD AD-RCMAR
and the CLRC because of their importance to the local region, the multilevel risks they experience, the
disproportionate burden of ADRD they carry, and their lack of representation in population-based ADRD
research. To accomplish this goal, the CLRC will a) provide education in community-engaged research best
practices as well as coordinate with the REC to ensure all offered training is culturally and linguistically
appropriate and incorporates DEIA principles, b) build and strengthen community collaborations and
community engagement to facilitate community-driven partnerships with a Community Advisory Board (CAB)
and community based organizational (CBO) partners, and c) lead the recruitment and retention efforts for
ADRD research within our priority populations by developing and disseminating a first-of-its-kind Community
Driven Plan for ADRD Research (CDP-AD) to amplify the community’s voice about their needs for ADRD
research.